INDINAVIR--EFFECT ON CARBOHYDRATE METABOLISM IN HIV PATIENTS

The primary outcome variable will be insulin sensitivity, which will be calculated minimal model analysis of the IVGTT insulin and glucose data. Insulin sensitivity will be compared among baseline, 2 week and 8 week testing times by repeated measurs ANOVA. Secondary outcome measures will be first phase IVGTT insulin response, IVGTT incremental insulin area between 0-240 minutes, and the OGTT glucose and insulin total areas (trapezoid method).